Administration and Statistics

PROJECT SUMMARY – CORE 1
Core 1 will advance the overall goals of the FusOnc Program Project by providing administrative and statistical
support that promotes collaborative interactions, cost-effective resource utilization and sharing, statistically
rigorous study design and data analyses, and synergistic integration of data across all Programs and Cores of
the Program. As administrative support, Core 1 will (1) provide organizational, administrative, fiscal, and
scientific management, (2) arrange recurring meetings to ensure timely and productive interactions across all
Project and Core teams, and (3) facilitate regular interactions with internal and external advisors through
regularly scheduled meetings. Core 1 will provide statistical expertise for rigorous experimental design by
performing power calculations to determine sample size and planning batches to minimize the confounding of
technical and biological effects. It will also provide statistical expertise for routine data analysis with appropriate
application of existing methods. Finally, Core 1 will perform integrative analyses of data across Projects and
Cores by applying and extending existing integrative data analysis methods and developing novel integrative
data analysis methods. In these ways, Core 1 will promote the successful completion of the overall goals of the
FusOnc Program Project to advance mechanistic understanding of fusion oncoprotein-driven pediatric cancers
and propel the development of mechanism-based targeted therapies against these cancers.

Public health relevance
PROJECT NARRATIVE – CORE 1 Core 1 will (1) administer and manage synergistic interactions of all Project and Core research teams and (2) organize and conduct annual meetings with Internal and External Advisory Boards. Core 1 will also provide statistical support for (1)study design and routine data analyses, and (2) integrative statistical analysis of data across all Projects and other Cores. In these ways, Core 1 will promote the successful completion of the overall goals of the FusOnc Program Project to advance mechanistic understanding of fusion oncoprotein-driven pediatric cancers and propel the development of mechanism-based targeted therapies against these cancers.